THE ROLE OF A-BETA SPECIES IN VASCULAR SMOOTH MUSCLE CELL AND CEREBRAL ARTERIOLE

DESCRIPTION (provided by applicant): The role of Aβ species in vascular smooth muscle cell and cerebral arteriole dysfunction. Alzheimer's Disease (AD) is the leading cause of dementia; yet no therapy exists to slow or stop its progression. Recently, cerebrovascular (CV) pathology has been identified as a strong contributor to AD. Two key observations suggest that amyloid-β peptide (Aβ) may play a role by either causing or increasing the susceptibility to cerebral ischemia. First, cerebral blood flow (CBF) is reduced in early stages of AD, and the reactivity of cerebral blood vessels is impaired - both of which have been linked to the vasoactive properties of Aβ. Second, most AD patients develop Aβ deposits not only in brain but also in vessels - a condition known as cerebral amyloid angiopathy (CAA). CAA is a powerful risk factor for brain infarction and dementia, and is associated with severe CV dysfunction. A2 exists in several forms including soluble monomers (such as Aβ40 and Aβ42), soluble oligomers (toxic intermediate species), and insoluble fibrils (principle component of CAA). The former (primarily Aβ40) and the latter (fibrillar A2 in the form of CAA) have been shown to powerfully alter CV function, while the vascular effects of A2 oligomers are not known. Our preliminary data suggest that the manner and extent to which monomeric A2 vs. fibrillar A2 cause CV dysfunction is different. We find that Aβ monomers cause a hyper-contractile vascular phenotype that is due to endothelial cell (EC) and vascular smooth muscle cell (VSMC) dysfunction that is mediated via reactive oxygen species (ROS), while Aβ fibrils in the form of CAA cause a hypo-contractile vascular phenotype that is primarily due to VSMC dysfunction that is mediated via ROS. We also identified a previously unrecognized contribution of ROS to CAA formation. The long-term objective of the proposed project is to test the central hypothesis that Aβ species powerfully and adversely affect the cerebral circulation by inducing VSMC-mediated arteriole dysfunction via an ROS- mediated pathway. The specific aims are 1) to determine whether Aβ species cause differential CV effects (hyper- vs. hypo-contractile impairment); 2) to determine the ROS pathways by which Aβ species cause VSMC and cerebral arteriole dysfunction; and 3) to determine the manner and extent to which ROS contribute to CAA formation, and to assess the functional benefits of reducing CAA via anti-ROS strategies. Methods used will include a) in vitro assessment of VSMC function after application of exogenous Aβ species; b) in vivo assessment of cerebral arteriole function in transgenic mice producing endogenous Aβ species; c) immunotherapy with anti-Aβ antibodies that bind Aβ40, Aβ42, Aβ oligomers, and/or Aβ fibrils; d) pharmacologic and genetic inhibition of NADPH oxidase; d) pharmacologic and genetic inhibition of the A2-binding cell surface receptors, LRP1 and HSPGs; and e) quantitation of CAA, Aβ40, Aβ42, APP, and ApoE. If successful, these studies will result in an improved understanding of the mechanisms underlying Aβ-induced CV deficits and CAA formation. This will likely facilitate development of therapies targeting Aβ and its downstream effectors, which may ultimately improve the outcome of patients with AD, CAA, or both.

Public health relevance
PUBLIC HEALTH RELEVANCE: The role of Aβspecies in vascular smooth muscle cell and cerebral arteriole dysfunction. Alzheimer's Disease is the most common cause of dementia and the 6th leading cause of death in the United States; yet no effective treatment exists. Recently, stroke has been identified as a contributor to the memory problems of patients with Alzheimer's Disease. The goal of this project is to use cell culture and genetically engineered mice to improve our understanding of the factors that predispose Alzheimer's Disease patients to stroke. If successful, the results of the project may point to ways to develop effective treatments to prevent or reverse the memory problems of patients with Alzheimer's Disease in the future.